Neutral Sphingomyelinase in Breast Cancer

PROJECT SUMMARY
Bioactive sphingolipids including ceramide (Cer), constitute a family of related molecules implicated
in many processes pertinent to tumorigenesis. Because of its pro-death and anti-growth functions, we
have proposed Cer to function as a tumor suppressor lipid, yet our ability to mechanistically define its
role in tumor behavior has been hampered by lack of molecular tools. This proposal builds on recent
studies and results that have identified neutral sphingomyelinase-2 (N2), a key Cer-producing enzyme,
as an epigenetically suppressed gene in in breast cancer (BC) and that it displays tumor suppressor
functions in cells and in vivo. Based on these novel data, we advance the hypothesis that N2 is an
important tumor suppressor enzyme, acting through Cer and downstream signaling pathways to
suppress anchorage-independent growth (AIG) and to prevent BC progression and metastasis. This
also offers specific therapeutic potential by ‘reactivating’ the N2 pathway and/or exploiting it in synthetic
lethality studies. This hypothesis will be tested by pursuing the following specific aims: In Aim 1, we
will establish N2 as a tumor suppressor in vivo, define its role in AIG, and define the mechanisms of its
action with a specific emphasis on YAP/TAZ driven signaling. In Aim 2, we will advance the N2 pathway
as a novel target in BC taking a two-pronged approach: 2a) define the ‘reciprocal’ enzyme(s) that
metabolizes N2-generated Cer and develop it as therapeutic targets; and 2b) identify targets that are
synthetically lethal with loss (suppression) of N2. Taken together, these results will define the N2/Cer
pathway as a novel tumor suppressor pathway with a key function in suppressing AIG, a hallmark of
transformation that is surprisingly understudied. Our studies will further dissect novel mechanisms of
N2 action, through a heretofore unappreciated link of Cer to the Yap/Taz pathway. Finally, these studies
will also advance the N2/Cer axis as a viable therapeutic target through innovative strategies.

Public health relevance
PROJECT NARRATIVE The studies proposed in this project aim at defining how an enzyme of lipid (fat) metabolism (neutral sphingomyelinase) regulates some key functions of cancer cells that result in suppression of tumor promoting activities. Understanding these novel pathways and mechanisms not only enhances our understanding of critical aspects of cancer behavior, but also promises to lead us to the identification of novel targets for developing new inhibitors of cancer metastasis.